Addressing Obesity in Early Care and Education Settings

PROJECT SUMMARY
Childhood obesity is a national epidemic that disproportionately burdens low income and ethnic minority
communities. By preschool, nearly one-third of low income children are already overweight or obese, setting
the stage for a myriad of adverse health conditions in adolescence and adulthood. Experts agree that effective,
scalable, and sustainable obesity prevention efforts are urgently needed and must shift their focus to early
childhood. Preschools offer a very promising environment for implementation and wide dissemination of
interventions targeting large numbers of young children. However, limited rigorous implementation research
targeting low income and ethnic minority preschool age children has left a major evidence gap, severely
constraining the tools available to educators and policymakers to address the obesity epidemic. Individually-
focused and single-component interventions have generally failed to produce long-term changes in obesity-
related outcomes. Evidence increasingly supports creating entire environments (e.g., preschools) where the
healthy choice is the default option.
Therefore, we propose to conduct a pragmatic cluster randomized trial, based on our Healthy-By-
Default framework, to evaluate the effectiveness and implementation of a multi-level, multi-component
intervention that integrates healthy eating and physical activity into preschool routines. Our intervention will
involve 1) establishment of organization-level policies to support healthy nutrition and physical activity, 2)
integration of nutrition and physical activity into the preschool curriculum, 3) modeling of healthy behaviors by
preschool teachers and staff, and 4) engagement of parents as partners in this effort. The study is a
collaboration between UCLA and the Child Care Resource Center (CCRC), a large non-profit organization
dedicated to ensuring that all children receive high quality, comprehensive preschool/child care experiences,
particularly in low resource, diverse communities. We will randomly assign 60 preschools served by CCRC, in
underserved areas of Los Angeles County, to the intervention or a usual practice, wait-list control condition.
Our aims are to: 1) implement a multilevel obesity prevention intervention for preschool settings that
builds on existing evidence-based approaches, stakeholder input, and our pilot research; 2) evaluate the
effectiveness of the intervention on child BMI z-scores (primary outcome), and parent-reported child nutrition
and physical activity (secondary outcomes); and 3) systematically assess intervention reach, adoption,
implementation, adaptation and maintenance, guided by the RE-AIM Framework, which we have tailored for
our specific study focus and setting. By simultaneously evaluating both effectiveness and implementation of
our intervention, we will efficiently generate new knowledge vital to informing widespread dissemination. Given
the staggering long-term societal costs of childhood obesity, rigorous studies to identify effective and scalable
obesity prevention interventions are needed now.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT This project addresses a pressing public health issue and health disparity; fills a critical evidence gap regarding implementation and evaluation of effective interventions to address childhood obestiy; takes an organization- level approach informed by our Healthy-by-Default framework to maximize impact; and greatly increases likelihood of sustainability and scalability through integration of the intervention into the preschool system.